Development of a culturally informed method of evaluating emotion socialization within Latino families

PROJECT SUMMARY
Adaptive emotion regulation skills can help to promote resilience in children by mitigating the risk for
psychopathology associated with a range of risk factors including parental mental health problems, childhood
maltreatment, and violence exposure. Importantly, Latino children and youth are at an increased risk for mood
disorders yet less likely to receive treatment, as compared to European American youth, with more than a
million Latino youth suffering in 2019, only 37% of whom received treatment. Supporting the development of
adaptive emotion regulation skills may be one way to reduce these disparities. However, Latino families are
rarely included in research on children’s socioemotional development, and therefore may be left behind from
the advances in interventions in this area. A primary means by which children develop adaptive emotion
regulation skills is from their parents’ use of emotion socialization parenting behaviors (ESPBs), including
parents’ modeling of their own emotional responses, direct teaching about emotions and regulation skills, and
responses to their children’s emotional displays. ESPBs are related to emotional functioning and psychosocial
outcomes in children of all ages and thus can be an important target for intervention. However, most of what
we know about these parenting behaviors is based upon research conducted predominantly with European
American samples. There is reason to believe that Latino parents’ ESPBs may differ from those of European
American parents because parents possess culturally-influenced beliefs about emotions that guide their
response to and shaping of their children’s emotional experience, expression, and regulation. Yet very little is
known about ESPBs in Latino families. The current study aims to expand our understanding of emotion
socialization processes in Latino families and generate a culturally informed measure for assessing them that
can be used to evaluate the impact of interventions on parenting and ensuing child outcomes. We propose to
utilize an exploratory mixed methods design to deepen our understanding of ESPBs among Latino families and
establish a culturally informed and linguistically valid method for assessing them. Qualitative and quantitative
methods will be used to improve our ability to validly evaluate ESPBs and their impact on Latino children (ages
6-12). Specifically, this study will pursue three aims: (1) Strengthen our understanding of ESPBs among Latino
parents utilizing focus groups with 48 Latino parents to enhance our knowledge. This information will inform an
adaptation of an existing widely used assessment tool, the EAC (with support of its authors) which will be
carefully translated into two Spanish-language versions appropriate for use by individuals of Mexican or Puerto
Rican origin; (2) Examine the factor structure and test the reliability of the modified EAC via an on-line national
survey of parents of Mexican or Puerto Rican origin; and (3) Establish the convergent validity of the modified
EAC. With this tool in hand, we can more sensitively develop and evaluate ESPB interventions for Latino
families.

Public health relevance
PROJECT NARRATIVE Children’s adaptive emotion regulation skills can both optimize healthy socioemotional development and protect against the negative impact of adverse experiences, such as maltreatment, caregiver mental health problems, and violence exposure. Although emotional experiences are culturally bound, little is known about the parenting behaviors used by Latino parents to socialize their children’s emotion regulation skills. The current study aims to address this gap by generating a deeper understanding of emotion socialization processes within Latino families, creating a culturally-informed adaption of an emotion socialization assessment tool for use with Latino families, and examining the factor structure, reliability and validity of the adapted measure.